Development of Human Anthrax Immune Globulin

The Development of the Human Anthrax Immune Globulin (AIGIV) contract supports studies to assess the efficacy of anthrax immune globulin for intravenous use (AIGIV) as a therapeutic for anthrax disease.